Quantifying the Roles of Positive and Negative Stimulation in T Cell Receptor Signaling

? DESCRIPTION (provided by applicant): The next step in cancer treatment is cancer immunotherapy, which seeks to fine tune our own immune responses against cancer through careful modulation of anti-tumor T cell responses as opposed to directly attacking cancer cells with harmful treatments such as radiation or chemotherapy. Effectively manipulating T cell responses against cancer without causing adverse effects requires striking a delicate balance between positive and negative T cell stimulation signals, essentially the gas and brakes of T cell responses. These stimulation signals are received by the T cell and transmitted through an intricate web of signaling pathways before ultimately being translated into a response, which may be to either attack or retreat. Achieving a quantitative understanding of how intracellular signaling processes determine the outcome of T cell encounters with cancer cells, which deliver both positive and negative stimulation signals, is a critical step in the drug design process. The goal of this proposal is to use mathematical modeling to determine the mathematical rules governing T cell responses to different stimulation signals. In general, insights gained during thi research may lead to a deeper understanding of the signaling mechanisms underlying T cell responses. Specifically, the quantitative relationships between upstream stimulation signals and downstream responses uncovered by this work may suggest clinically relevant, testable hypotheses such as predictions of which T cell receptor-targeting drugs and drug combinations may be more effective than others at eliminating cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goals of this project are to uncover the mathematical rules that govern a particular aspect of our immune response to cancer and which may be hidden in current experimental data. Completion of this proposal has the potential to make an impact on the development of better cancer fighting drugs.